Loopholes, Enforcement Challenges, and Tobacco Industry Interference with Tobacco Control Policies

PROJECT SUMMARY/ABSTRACT
Background. Enactment of tobacco control policies is a vital response to the ongoing epidemic of adolescent
e-cigarette use in the US and is believed to have contributed to the decline in youth e-cigarette use from 2019
to 2020. During 2019-2020, two federal laws were enacted: (1) Tobacco 21 (increased the minimum legal
sales age for tobacco to 21 years; T21) and (2) a partial Flavor Restriction law eliminated pod/cartridge-based
e-cigarette products that contained flavors other than mint/menthol. While traditional policy evaluations (e.g.,
compliance checks, document analyses, and surveys) have been employed to evaluate policy impact,
complementary and innovative social media-based methodologies can be used to systematically examine
organic public discussion about policy-relevant issues. Such data are particularly valuable due to the ability to
uncover critical policy-relevant information, taking less time than traditional methodologies. Building on my
experience and learning from my research mentors’ expertise, I will conduct the first comprehensive social
media assessment aimed at uncovering highly valuable yet often difficult-to-ascertain information regarding
emerging tobacco access laws (that have already been enacted or are currently being discussed) in three
areas: policy efficacy, enforcement challenges, and industry interference. Research. The overarching goal of
the proposed investigation is to reduce youth/young adult access to tobacco products. Therefore, in this
proposal, we will (1) identify loopholes that may circumvent emerging federal tobacco access laws; (2) identify
key challenges related to enforcement of FDA regulated tobacco access laws; and (3) investigate tobacco
industry supported interference with emerging FDA regulated tobacco access laws. To achieve these aims, we
will use a specialized software and a comprehensive list of social media-optimized search terms to collect data
from several social media platforms (e.g., Twitter, Instagram, Reddit, Facebook). Using a two-step process, we
will ensure search strings are comprehensive, feasible, specific, and informal. After developing a codebook to
explore sentiment (positive, negative, neutral, and mixed/both) about tobacco youth access laws, two trained
independent coders will code a sub-sample of collected data, stratifying by month, day, and time. Finally,
content analyses and social network analyses will be used to explore loopholes, enforcement challenges, and
interference with emerging tobacco access laws. Training. Pedagogically, the training plan for this proposed
K01 is comprised of didactic training (certificate program, workshop, coursework, seminars), mentoring
(directed research, conference calls, in-person contact hours, readings), and dissemination deliverables
(publications, presentations, and proposals) required to complete the project on the projected timeline.
Outcomes from these research aims will complement my career-development aims (i.e., developing expertise
in tobacco control policies, social media analysis, and social network analysis) that focus on the intersection
between health, policy, communication, and technology.

Public health relevance
PROJECT NARRATIVE Tobacco access laws are intended to prevent youth and young adults from initiating and using all tobacco products; however, research about policy efficacy, enforcement challenges, and communication the tobacco industry has with the public about federal tobacco regulatory laws has only been explored through limited, traditional research methodologies. The training and proposed research in this career development award application will use publicly available social media (e.g., Twitter, Facebook) data to organically and systematically examine policy loopholes that circumvent policy efficacy, key challenges related to enforcement, and tobacco industry interference among emerging youth access laws (e.g., Tobacco 21, Flavor restriction policies, a maximum nicotine level law). This innovative research would provide the FDA with prompt, action- oriented recommendations about these policies which can enable the FDA to make meaningful responses to critical issues including policy loopholes, enforcement practices, and industry interference.